Admin-Core

Modified Project Summary/Abstract Section

The Administrative Core manages the Center for Targeted Therapeutics (CTT) at the University of South Carolina (USC) in all of its organizational, fiscal, reporting, program building, communication, and evaluation aspects. During CTT COBRE Phase 3, the Administrative Core will have the following aims: 1). To manage all the organizational, fiscal, scientific oversight, communication, reporting and evaluation aspects of the CTT. To attain this, the Administrative Core will coordinate and promote the activities of the three research cores of the CTT, interact with other USC components for the fiscal management of the CTT, organize the meetings of the Advisory Committee (AC); collect, organize and redistribute as appropriate all the information needed for AC reporting and evaluation of the CTT. The Administrative Core will produce and submit the Annual Progress Report for the NIH IDeA program; maintain a web presence to connect the CTT with the USC academic units, other IDeA programs/centers inside and outside the state, the NIH IDeA program, and the scientific community. 2) To administer the Pilot Project program supporting Targeted Therapeutics research. The Pilot Project program will provide competitive funding for Targeted Therapeutics research projects each year, aimed at generating preliminary data leading to grant applications. In addition to conducting the competition for Pilot Projects, the administrative core will implement specific strategies to identify and promote priority scientific areas for support through the Pilot Project program and arranging collaborations. The administrative core, together with the AC, will select Pilot Projects for funding and monitor their productivity and impact on the career development of Pilot Project Leaders (PPL). 3). To foster the growth and expansion of Targeted Therapeutics research at the University by organizing and managing monthly CTT meetings, biannual meetings with the AC and annual symposia, as well as invited seminars. The Administrative Core will also mediate the monitoring of the pilot research projects and the review of drafts of grant proposals and manuscripts, coordinate opportunities for brainstorming and the generation of ideas, and identify priority scientific areas for future CTT growth. The Administrative Core will support the submission of team-based grant proposals and grow a research environment conducive to the development of young scientists and to acceleration of discoveries with inherent translational applicability. 4). To perform the evaluation of the CTT Program by utilizing a series of milestones and metrical indicators that have been developed. The administrative team will be responsible for conducting the evaluation process, assessing it against the established indicators and taking corrective actions if needed. Reports on the evaluation outcomes will be provided to the AC to receive feedback and recommendations for the appropriate course of action.